Studies in Amide and Peptide Synthesis

4.2.1 Project Summary and Relevance
This proposal seeks support to develop a fundamentally new approach to amide and peptide chemical
synthesis, one that complements existing methods based on dehydrative amide synthesis using
carboxylic acids and amines. Bromonitroalkanes serve as carboxylic acid surrogates in a direct amide
synthesis that utilizes an amine acceptor and an activating agent (a halonium ion). The concise
preparation of amides derived from nonnatural amino acids, common constituents of biologically active
linear and cyclic peptides that have been isolated from natural sources, is a central theme. Without this
new paradigm, alternative chemical methods would provide access to the desired amides at rising cost
due to the large number of steps required to prepare complex peptides, and the contamination of
intermediates and products by stereoisomers that are difficult to remove.
The practical chemical synthesis of biologically active peptides is an immediate goal. In the short term,
peptides of modest size (~10 residues) will be prepared and diversified. In the long term, this innovative
approach to amide synthesis will be used in combination with conventional methods to provide access
to large peptides (e.g. biologics) modified site-specifically with nonnatural amino acids.

Public health relevance
Project Narrative This proposal describes the development of new synthetic methods to prepare amide and peptide (polyamide) and heterocyclic small molecules. Peptides have increasingly impacted human health through their use as therapeutics – so-called biologics – while heterocycles are platforms common to drug development. The development of innovative new methods for their synthesis stand to further accelerate the discovery and development of a wide range of therapeutics.